RAMP3 Modulation of GPER1 Function in Cardiovascular Disease

DESCRIPTION (provided by applicant): Sex-dependent differences in cardiovascular disease (CVD) susceptibility and progression may be estrogen-mediated, but the genetic pathways regulating estrogen cardioprotection have yet to be elucidated. Receptor Activity Modifying Proteins, or RAMPs, are transmembrane accessory proteins that are known to interact with G-protein coupled receptors (GPCRs) and play a role in receptor trafficking and ligand specificity. RAMP3 is unique in that it is transcriptionally induced by estrogen and CVD. Also, unlike other RAMP family members, RAMP3 is known for its ability to alter GPCR recycling to the plasma membrane through a PDZ motif-dependent association with NSF. GPER1 is a novel cardioprotective estrogen-binding GPCR that is present in increased levels in females and in CVD. Our preliminary findings have shown that genetic loss of RAMP3 leads to reduced levels of GPER1 at the plasma membrane of cardiac cells in a sex-dependent fashion, providing evidence for an interaction of RAMP3 with GPER1. We will investigate the potential interaction between RAMP3 and GPER1 in vitro using transfected cells to determine whether RAMP3 can alter GPER1 recycling to the plasma membrane. In addition we will perform in vivo studies to determine whether pharmacological activation of GPER1 signaling affects the cardiovascular phenotype of RAMP3-/- male and female mice on a genetic background of heart failure. Results from this proposal will elucidate the role of RAMP3 and GPER1 in sex-dependent cardioprotection and have the potential of identifying novel therapeutic targets for gender-tailored treatment of CVD.

Public health relevance
PUBLIC HEALTH RELEVANCE: Narrative Heart Disease is a common health condition that ranks as the leading cause of death for both men and women in the United States, causing over 630,000 deaths each year. This means that one out of every four deaths in the U.S. is due to heart disease. Though heart disease affects both men and women, for reasons we do not fully understand, it affects the two sexes differently. Prior to menopause, women are generally protected from heart disease while men of the same age are at increased risk in comparison. However, after menopause, a woman's risk of developing heart disease drastically increases. Sex-dependent differences in heart disease susceptibility and progression may be mediated by estrogen, but the genetic pathways that regulate this effect have not yet been clearly identified. In this research proposal we will investigate specific signaling pathways that may be involved in the sex-dependent differences of heart disease. Because heart disease is such a prevalent and serious threat to American health, these studies are important to clarify the mechanisms that underlie the development and progression of this condition, with the overall goal of improving human health. Narrative Heart Disease is a common health condition that ranks as the leading cause of death for both men and women in the United States, causing over 630,000 deaths each year. This means that one out of every four deaths in the U.S. is due to heart disease. Though heart disease affects both men and women, for reasons we do not fully understand, it affects the two sexes differently. Prior to menopause, women are generally protected from heart disease while men of the same age are at increased risk in comparison. However, after menopause, a woman's risk of developing heart disease drastically increases. Sex-dependent differences in heart disease susceptibility and progression may be mediated by estrogen, but the genetic pathways that regulate this effect have not yet been clearly identified. In this research proposal we will investigate specific signaling pathways that may be involved in the sex-dependent differences of heart disease. Because heart disease is such a prevalent and serious threat to American health, these studies are important to clarify the mechanisms that underlie the development and progression of this condition, with the overall goal of improving human health. __SpecificAimsTextDelimiter__ Specific Aims Sex-dependent differences in cardiovascular disease (CVD) susceptibility and progression may be estrogen-mediated, but the genetic pathways regulating estrogen cardioprotection have yet to be elucidated. Receptor Activity Modifying Proteins, or RAMPs, are transmembrane accessory proteins that interact with GPCRs and play known roles in receptor trafficking and ligand specificity. RAMP3 is unique in that it is transcriptionally induced by estrogen and CVD. Also, unlike other RAMP family members, RAMP3 is known for its ability to alter GPCR recycling to the plasma membrane through a PDZ motif-dependent association with N-ethylmaleimide-sensitive factor (NSF). A specific GPCR of interest in CVD is GPER1, a novel cardioprotective estrogen-binding GPCR that is present in increased levels in females and in CVD. Therefore, we are interested in examining potential roles of RAMP3 and GPER1 in gender-dependent differences in CVD. Figure 1 Our preliminary findings have shown that RAMP3 is upregulated in a sex-dependent fashion in RenTgMK (RTG) mice, a genetic model of angiotensin II-mediated CVD. When RAMP3-/- mice, which were first generated and characterized by our lab, are bred to RTG mice, we discovered that genetic loss of RAMP3 exacerbated cardiac hypertrophy and heart failure in male but not female mice. Previous studies from our lab have also shown that genetic loss of RAMP3 leads to reduced levels of GPER1 at the plasma membrane of cardiac cells, a finding that also varied between male and female mice. The unique features of RAMP3 suggest that a pathway such as NSF-dependent receptor recycling is involved in GPER1 localization via RAMP3. Taken together these findings provide evidence for an interaction of RAMP3 with GPER1 and drive us to hypothesize that RAMP3 is a potent cardioprotective factor mediating sex-dependent differences in CVD through its interaction with the estrogen GPCR GPER1. As depicted in Figure 1, a role for RAMP3 in facilitating increased GPER1 receptor recycling at the plasma membrane would explain the sex-dependent effect of RAMP3 loss in the male compared female CVD mouse model, as efficient recycling of the cardioprotective GPER1 maybe more critical in the male heart, where estrogen and GPER levels are comparatively low. Our proposed studies seek to identify the RAMP3-GPER1 interaction as a sex-dependent cardioprotective factor that contributes to differences in CVD progression between men and women. In Specific Aim 1, we will test the hypothesis that RAMP3 associates with GPER1 and functions to promote NSF-associated recycling of GPER1 to the plasma membrane in vitro. We will use transfected COS-7 cells to characterize the nature of the RAMP3/GPER1 interaction via BRET. We will also perform co-transfection with NSF as well as a RAMP3 construct mutated in the PDZ domain to determine whether these conditions alter the RAMP3/GPER1 interaction. Results from this aim will help clarify the controversy over GPER1 cellular localization, identify a new GPCR association for the RAMP family, and will identify a potential mechanism for estrogen-mediated cardioprotection. In Specific Aim 2, we will test the hypothesis that pharmacological activation of GPER1 in RTG and RTG:RAMP3-/- mice will alter CVD progression in a sex- and genotype- dependent fashion. We will determine whether male and female RAMP3 +/+ and RAMP3-/- mice on the background of RTG-induced heart failure respond differently to treatment with a specific agonist of GPER1, resulting in differences in their CVD phenotype. Results from this aim will define a sex-dependent cardioprotective mechanism in vivo and may identify a potential therapeutic option for sex-tailored treatment of CVD. Results from these studies will define the roles of RAMP3 and GPER1 in CVD and may elucidate novel paradigms underlying sex-dependent differences in CVD susceptibility and progression, which may lead to novel therapeutic targets for gender-tailored treatment of CVD.